MYOCARDIAL SALVAGE BY CORONARY REPERFUSION

The aim of this study is to investigate whether a new myocardial perfusion imaging agent may be used to quantify the area of ishcemic myocardium during coronary occlusion and the myocardial salvage during coronary reperfusion.